Central Operations Core

Summary: Central Operations Core The Philippine Molllusk Symbiont ICBG will rely on a Central Operations Core led by Margo Haygood, Oregon Health & Science University. This project element is responsible for project wide activities and responsibilities. By keeping the funds for these activities centralized, our agility, flexibility and ability to adapt to circumstances are maximized. Functions provided include: communication, travel and visitor arrangements, student and postdoctoral support, publications, database management and legal arrangements.

Public health relevance
Narrative: Central Operations Core The Philippine Mollusk Symbiont ICBG Central Operations Core provides support and project-wide functions such as communication, travel and visitor arrangements, student and postdoctoral support, publications, database management and legal arrangements. The Core provides logistical support for our overall plan to obtain new compounds that might hold therapeutic potential in treating diseases of the nervous system, cancer, parasitism, and infectious diseases.